A Pathomimetic Gingiva-on-a-Chip for Assessing Microbiota-Directed Anti-Inflammatory Therapeutics

PROJECT SUMMARY/ABSTRACT
Periodontitis, or severe gum disease, is one of most prevalent inflammatory conditions worldwide. Left untreated,
it ultimately results in the loss of teeth, while also increasing risk for several comorbidities, including heart
disease, diabetes, and rheumatoid arthritis. The etiology of periodontitis is strongly tied to an ecologically
imbalanced oral microbiota, in which disease-promoting microbes (pathobionts) proliferate at the expense
health-promoting microbes (symbionts). Despite this, current periodontitis treatments, such as the debridement
of dental plaque, indiscriminately eliminate both pro-inflammatory pathobionts and beneficial symbionts. A major
benefit of symbionts stems from their capacity to produce antimicrobials that suppress pathobionts. Selectively
enhancing the production of such antimicrobials could therefore represent a more targeted therapeutic option for
periodontitis. In preliminary studies, we found that that an abundant diet-derived metabolite in human saliva,
nitrate, can be converted by symbionts into an antimicrobial (nitrite) that inhibits pathobionts. To identify
additional metabolites with similar activity, we performed an initial screen using ex vivo human saliva cultures,
revealing that the plant metabolite arbutin also inhibits pathobionts in a microbiota-dependent manner. In line
with these findings, it has been consistently reported that nitrate-rich foods, such as leafy greens, can reduce
microbiota imbalance and even gingival inflammation, while in other disease settings, arbutin has also been
reported to dampen inflammation. However, whether these metabolites are anti-inflammatory because they
induce symbionts to inhibit pathobionts has not been fully elucidated. Furthermore, numerous other symbiont-
promoting metabolites that target pathobionts likely await discovery, necessitating accurate high-throughput
modeling of oral microbiota-host crosstalk to probe downstream impacts on gingival inflammation. To this end,
we propose leveraging our experience in microphysiological (Organ-on-a-Chip) systems to develop a novel
Gingiva-on-a-Chip. This microfluidic device will recapitulate key physico-chemical aspects of the periodontal
disease site (crevice between gum and tooth), while enabling stable co-culture of epithelial cells with human oral
microbiota. Using this bioengineered model, we will pursue the following Aims to explore the anti-inflammatory
potential of symbiont-promoting metabolites. In Aim 1, we will utilize Gingiva Chips to test whether nitrate reduces
inflammation by inducing symbionts to inhibit pathobionts, while in Aim 2, we will expand our initial screen to
identify additional novel microbiota-dependent antimicrobial metabolites, before again utilizing Gingiva Chips to
assess their impacts on inflammation. The successful completion of this project will result in an improved
technology for deciphering oral microbiota-host interactions, while reinforcing the novel concept that symbiont-
promoting metabolites can be translated into targeted microbiota-directed therapies to ameliorate inflammation.

Public health relevance
PROJECT NARRATIVE Periodontitis (gum disease) remains one of the most prevalent microbiome-driven inflammatory conditions worldwide because 1) current therapies (e.g., dental cleanings) non-specifically eliminate both harmful and beneficial oral microbes and 2) current experimental models insufficiently capture the dynamic periodontitis disease site, hindering our ability to accurately model oral microbiome-host interactions and innovate more targeted therapies. Recently, we discovered that a highly abundant compound in saliva, nitrate, can be converted by beneficial microbes into an antimicrobial that selectively inhibits harmful microbes, but whether this microbe- dependent mechanism underlies the anti-inflammatory properties of nitrate, or other unidentified compounds, has yet to be fully explored. This project will develop a novel biomimetic platform (Gingiva-on-a-Chip) to examine the possibility of translating nitrate, as well as novel compounds with microbe-dependent antimicrobial activity, into more targeted anti-inflammatory therapeutics for periodontitis.